Community Partnership, Outreach and Education Core (CPOEC)

Modified Project Summary/Abstract Section

ABSTRACT/SUMMARY: Community Partnership, Education, and Outreach Core
The PEACE Center’s Community Partnership, Outreach and Education Core (CPOEC) will be an integral part of the proposed center and will help guide and direct all aspects of the Center’s activities to ensure widespread benefit from innovative research findings. The CPOEC will engage all Center components: the Research Projects, the Executive Committee, Steering Committee, and the Administrative Core. CPOEC activities will accelerate the typical timeline of research by creating dialogue from the outset on research questions that are inherently relevant to key stakeholders, including clinical and public health practitioners as well as patients and community members. The CPOEC seeks to address the significant health differences of uterine fibroids (UF), which disproportionately affect some subgroups of women, in part as a direct result of chronic stressors, differences in access to care, as well as differential knowledge and attitudes about UF and their treatment. Engaging the communities at risk with culturally competent and strategic partnerships is expected to make a significant impact on reducing differences in UF care and treatment. The overall objective of the CPOEC is to facilitate a new coalition between academic researchers and community organizations and stakeholders with ties to key subgroups – partnerships that will be empowered to creatively and organically study ways to address differences in uterine fibroid care and treatment using a community-based participatory research (CBPR) approach. The activities and products of the CPOEC will be significant to patients, clinicians, and researchers as we currently have limited data on the full spectrum of challenges faced by those most burdened by UF. The core’s aims were created by our community partners and Community and Stakeholder Advisory Board (CAB).

The CPOEC aims are as follows:
1) Establish a community-academic partnership with the capacity to conduct CBPR on UF health differences and pathways to health; 2) Provide UF health education, outreach, and increase community members capacity for CBPR and health research via local, regional, national, and social networks; 3) Ensure widespread dissemination of PEACE Center progress and findings; and 4) Continuously evaluate the effectiveness of the PEACE community-academic partnership ti fully engage all partners.